Pulmonary Mechanisms of Dyspnea in HFpEF: Impact of Obesity

Dyspnea on exertion (DOE) and exercise intolerance are hallmark symptoms of heart failure with preserved ejection
fraction (HFpEF). The mechanisms of these two symptoms are unknown. Potential mechanisms for DOE are
numerous and multifactorial, including pulmonary limitations, exercise ventilatory limitations, central cardiovascular
limitations, peripheral vascular/muscle limitations, autonomic control alterations, and lastly obesity. Obesity
decreases lung volume subdivisions and exaggerates the age-related decline in maximal expiratory flow increasing
the risk of expiratory flow limitation and dynamic hyperinflation during exercise, both responses associated with
DOE. Obesity also increases the energy requirement of exercise, ventilatory demand, the work of breathing, and
exercise intolerance; all these alterations can also influence DOE. Indeed, one third of obese adults experience
DOE and many HFpEF patients are obese. DOE can be attenuated in adults by exercise training due to ‘sensory
adaptation. However, the effect of obesity in HFpEF patients is underappreciated, in contrast to conventional
thinking, which assumes that increased pulmonary capillary wedge pressure (PCW) is responsible. The overall
objective of Project 4 is to investigate the mechanisms of DOE and exercise intolerance in obese and
nonobese HFpEF patients. Aim 1) We will examine the interaction of obesity (obesity-related alterations in
pulmonary function & body composition including abdominal fat) and HFpEF (underlying changes in lung function)
on ventilatory reserves at rest and during submaximal cycling exercise, and their associations (if any) with DOE and
exercise intolerance in obese HFpEF patients as compared with nonobese HFpEF patients, and obese and
nonobese patients without HFpEF. We hypothesize that breathing limitations due to obesity and HFpEF will
combine to limit ventilatory reserves during exercise, which will provoke greater DOE and exercise intolerance in
the obese HFpEF patients; Aim 2) We will investigate the effects of pulmonary vascular function (including the
effects of decreased PCW via sublingual nitroglycerin, SL TNG, treatment,) on DOE and exercise tolerance during
submaximal constant load cycling exercise (& during MR imaging for lung water content). We hypothesize that
DOE may not be decreased as much by SL TNG treatment in obese HFpEF patients as in nonobese HFpEF
patients since obesity-related respiratory limitations will not be altered by decreased PCW via SL TNG treatment;
and Aim 3) We will examine the effects of central and peripheral exercise limitations via endurance exercise
training coupled with SL TNG treatment (improved central cardiac function) and single leg kicking exercise training
(improved peripheral muscle/vascular function) on DOE and exercise tolerance in HFpEF patients during constant
load submaximal cycling exercise. We hypothesize that both central and peripheral exercise training will decrease
DOE to a greater extent in obese HFpEF patients due to sensory adaptation (i.e., vs nonobese patients). Our long
term goal is to understand the mechanisms of DOE and exercise intolerance in patients with HFpEF, and provide
novel results that could alter conventional approaches for treating DOE in patients with HFpEF.

Public health relevance
PROJECT NARRATIVE Dyspnea (breathlessness) on exertion (DOE) is a hallmark symptom of heart failure with preserved ejection fraction (HFpEF), but the mechanism is unknown. Potential mechanisms are numerous and multifactorial but we propose that obesity may be a major contributing factor, since many patients are obese, and one third of healthy obese adults experience DOE; conventional thinking assumes that increased pulmonary capillary wedge pressure is responsible for DOE in HFpEF. The overall goal of this project is to investigate the mechanisms of DOE in obese and nonobese HFpEF patients, and our approach will be to investigate three potential mechanisms of DOE in HFpEF patients: 1) breathing limitations due to the interaction of obesity- and HFpEF-related changes in lung function, 2) pulmonary vascular dysfunction; and 3) central (cardiac) and peripheral (vascular/muscle) limitations; therefore, we expect that these results will have broad and immediate clinical relevance to the treatment of dyspnea on exertion in patients with HFpEF, maybe the most common “untreatable” disease in the world.